Genetic mechanisms and evolutionary processes underlying diversity within and between species

Project summary
The long-term goal of this project is to understand the genetic mechanisms and evolutionary processes
responsible for generating phenotypic diversity within and between species. This includes discovering the
genes responsible for phenotypic divergence, identifying which changes within these genes affect the
phenotype, and determining how these changes alter molecular, cellular, and developmental processes. It
also includes figuring out how mutation and selection have worked together to give rise to these changes.
These goals will be accomplished by combining methods from developmental biology, evolutionary
genetics, genomics, and bioinformatics to study both fruit flies (Drosophila) and yeast (Saccharomyces).
Specific experiments proposed are designed to address the following three complementary questions: (1)
What are the genetic and molecular mechanisms underlying phenotypic differences? (2) How do regulatory
networks composed of cis- and trans-acting factors controlling gene expression evolve? and (3) What are
the relative contributions of mutation and selection to variation in gene expression? Taken together, this
work will advance our understanding of genotype-phenotype maps and how they vary within and between
species. Genetic changes affecting the regulation of gene expression, an essential step in translating
genotypes into phenotypes, will be given particular emphasis in this work. Ultimately, lessons learned from
these studies will contribute to a general framework for predicting and interpreting patterns of genotypic and
phenotypic variation, including variation related to human health.

Public health relevance
Project Narrative This project examines the genetic and molecular mechanisms responsible for the diversity of living things. This diversity includes variation within a species as well as between species. This work will improve public health because understanding how phenotypic differences arise on both evolutionary and developmental timescales provides insight into the origin and effects of genetic and molecular changes that impact not only normal trait variation, but also disease.